NIDCD Core for Clinical Research and Care

The NIDCD Core for Clinical Research and Care supports the following NIDCD projects:

1 Z01-DC-000016 NF-kappaB in the molecular pathogenesis and therapy of Neoplasms Affecting Human Communication
1 ZIA DC000039 Identification of Genes Causing Syndromic And Nonsyndromic Hearing Impairment
1 ZIA DC000046 Genetic Studies of Human Communications Disorders
1 ZIA DC000060 Molecular Analysis Of Human Hereditary Deafness
1 ZIA DC000064 Clinical Analysis Of Disorders Of Hearing And Balance
1 ZIA-DC-000073 Signal and Transcription Factor Network Interactions in Head and Neck Cancer
1 ZIA-DC-000074 Genomics and Proteomics of Head and Neck Cancer
1 ZIA-DC-000082 Neurotology Program
1 ZIA-DC-000087 Characterization & Enhancement of Anti-tumor Immune Responses in Head & Neck Cancer
1-ZIA-DC-000088 Cellular and Molecular Pathogenesis of Hearing Restoration in Adullt Inner Ear
1-ZIA-DC-000090 Mechanisms and Optimal Combination of Cisplatin Chemotherapy for Head and Neck Cancer

The NIDCD and collaborative protocols supported by the core include:
OH93-DC-0016 - Nonsyndromic Hereditary Hearing Impairment Gene Mapping: India / Pakistan Protocol
97-DC-0180 - Genetic Analysis of Human Hereditary Hearing Impairment
01-DC-0228 - Clinical and Molecular Analysis of Hearing Impairment with Enlarged Vestibular Aqueducts
01-DC-0229- Genetic Analysis of Hereditary Disorders of Hearing and Balance
12-DC-0152 - Normative values in audiovestibular testing
17-DC-0138 - Cisplatin and statins in ototoxcity
18-DC-0051 - NIDCD Biospecimens protocol
20-DC-0047 - Natural History and Genome Editing in Dominant Hearing Loss
21-DC-0002- Phase III Interventional Study using Atorvastatin to Reduce Cisplatin-Induced Hearing Loss
21-C-0009 - A Natural History Study of Children and Adults With Olfactory Neuroblastoma
000077 Clinical Data and Specimens in head and neck disorders
000141 Hearing Instability Phenotyping
15-D-0129 Dose-Escalation Study Evaluating the Safety of a Single Administration of an Adeno-Associated Virus Vector Encoding Human Aquaporin-1 in Irradiation-Induced Parotid Salivary Hypofunction
19-C-0041 Birinapant and Intensity Modulated Re-Irradiation Therapy (IMRRT) for Locoregionally Recurrent Head and Neck Squamous Cell Carcinoma
19-C-0002 A Phase II Study of M7824 in Subjects with Recurrent Respiratory Papillomatosis
20-C-0024 Anti-PD-L1/TGF-beta Trap (M7824) Alone and in Combination with TriAd Vaccine and N-803 for Resectable Head and Neck Squamous Cell Carcinoma Not Associated with Human Papillomavirus Infection
20-C-0155 Phase I/II Trial Investigating the Safety, Tolerability, Pharmacokinetic , Immune and Clinical Activity of SX-682 in Combination with M7824 With CV301 TRICOM in Advanced Solid Tumors
20-C-0104 Phase I/II Trial of HPV Vaccine PRGN-2009 Alone or in Combination with Anti-PD-L1/TGF-Beta Trap (M7824) in Subjects with HPV Positive Cancers
21-C-0013 A Phase I/II Study of Adjuvant PRGN-2012 in Adult Patients with Recurrent Respiratory Papillomatosis

The NIDCD Core for Clinical Research and Care supports over 3,000 outpatient clinic evaluations per year. Core otolaryngologists perform 50-100 major surgical cases annually. Staff mentor medical students during senior clinical clerkships. The Otolaryngologist Surgeon Scientist Career Development Program is coordinated through the OCD.